Developmental Funds

PROJECT SUMMARY/ABSTRACT (DEVELOPMENTAL FUNDS)
The University of Michigan Rogel Cancer Center (Rogel) seeks to reduce the burden of cancer and advance
health equity through transdisciplinary collaboration in research, education, patient care and community
outreach. The Center places a high premium on leveraging its CCSG Developmental Funds to expand and
enhance catchment area impact including research across the basic, translational, clinical, population science
continuum. Developmental Funds support activities that are consistent with goals and strategic priorities in
Rogel’s 2022-2027 Strategic Plan – Discoveries to Cures to Communities – which has six pillars: Research;
Community Outreach; Education and Training; Diversity, Equity, Inclusion and Justice; Infrastructure and
Clinical Research; and Patient Care. Rogel uses Developmental Funds to support new faculty recruitment, with
an emphasis on diverse, early-stage investigators, as well as innovative research pilot projects. As part of the
new strategic plan, Rogel senior leadership has identified high priority areas of research that will inform future
faculty recruitment, including researchers with expertise in the following areas: epigenetics, systems biology,
metabolism and metabolomics, mechanisms of treatment resistance, cancer immunology and immunotherapy,
early-stage clinical research, epidemiology, and cancer health equity, among others. Rogel also supports
members to advance their research with two types of pilot projects, both supported by Developmental Funds:
• The Innovation Award, for innovative, high-risk projects that stimulate new multi-investigator projects and
promote the development of new technologies
• The Catchment Area Award to support research in or related to the Rogel catchment area, including high
priority cancers and behavioral risk factors.